The Role of Ubiquitin and Ubiquitin-Like Molecules in Direct Antigen Presentation

Project Summary DESCRIPTION. The immune system must eliminate cells of the body that have become diseased as the result of intracellular infection or oncogenic transformation. CD8+ cytotoxic T cells are responsible for completing this task and must be able to distinguish healthy cells from diseased ones. Major Histocompatibility Complex Class I (MHC class I) molecules are present on most nucleated cells and are responsible for presenting antigen at the cell surface for CD8+ T cell inspection. In order to present antigen, the MHC class I pathway relies on binding to short peptides, created from degraded cellular proteins. When the source protein is associated with a disease (such as a viral protein or tumor associated protein) specific CD8+ T cells will recognize the peptide- MHC class I complex and kill the cell. Because the peptide provides the ultimate specificity in this reaction, we are interested in understanding how these peptides are created. Our data indicates that proteins which are rapidly degraded following their synthesis (termed Defective Ribosomal Proteins or DRiPs) are responsible for efficiently generating a supply of peptides. This proposal seeks to determine which cellular metabolic pathways are used to direct the rapid degradation of DRiPs and to determine if DRiPs are necessary in physiologically relevant settings. We are focusing on the ubiquitin conjugation pathway, as ubiquitin coupling is intimately associated with protein degradation. Ubiquitin-like proteins (UBLs) may also play a role in direct antigen presentation. The Specific Aims of this proposal are to identify how the ubiquitin-modifying enzyme Usp14 interacts with the antigen presentation machinery, understand why conjugation of the ubiquitin-like molecule Nedd8 is necessary for DRiP antigen presentation, and determine which E3 ubiquitin ligases are necessary for DRiP antigen presentation.

Public health relevance
Project Narrative There is a need to determine how diseased cells are identified by the immune system to effectively combat viral infections and oncogenic transformations. By determining how cells efficiently present diseased associated antigens, we will be able to target the molecular pathways which control the process. This information will be necessary in order to enhance clearance on infected or transformed cells or to diminish inappropriate responses.